Targeting brain and bone metastases in metastatic breast cancer for improved patient survival

A major clinical challenge in breast cancer is to prevent and to treat metastatic disease. Two key hurdles for
therapies for metastatic breast cancer (MBC) patients are to treat brain metastases (BrnMets) and to prevent
progression of bone metastases (BonMets). Chemotherapeutic drugs, including the taxanes, remain mainline
therapies for stage IV patients with MBC. However, prolonged clinical use of taxanes is associated with
development of multidrug resistance, dose-limiting hematopoietic toxicity, and neurotoxicity.
Our ongoing efforts in this area has led to an investigational new drug, Sabizabulin. Use of Sabizabulin in
MBC and other tumor models demonstrated suppression of primary tumor growth and tumor metastasis, and
effectiveness in overcoming taxane resistance. Since Sabizabulin has limited brain penetration, its further
modification led to the discovery of SB-216, a highly brain penetrable analog that has excellent efficacy in multiple
taxane-resistant tumor models. To further develop the SB-216 scaffold for MBC, the goals of this project are
to: (1) perform focused structural optimization based on the SB-216 scaffold to produce new potent and high
brain penetrable analogs that can overcome taxane resistance for MBC BrnMets management; and (2) develop
novel drug conjugates with bisphosphonate (BisPhos) for MBC bone BonMets treatment.
AIM 1. Perform focused structure-based optimization based on the SB-216 scaffold to develop new analogs
with high brain penetration ability. Crystal structures of tubulin/SB-216 complexes will be used to guide focused,
iterative lead optimization. We will screen new analogs in vitro using a panel of MBC cell lines, including cells
derived from PDX models, and normal cells. We will determine their brain penetrations to select the ten best
compounds for in vivo efficacy studies. AIM 2. Determine the in vivo efficacy of selected SB-216 analogs for
suppressing MBC BrnMets. We will first determine the maximum tolerable dose and pharmacokinetics for
selected SB-216 analogs from Aim 1 to identify the overall best three analogs for in vivo evaluation using multiple
well-characterized, pre-clinical models of MBC, including taxane-refractory models, each with pre-existing
BrnMets to score for delay of metastatic progression. AIM 3. Conjugate Sabizabulin, SB-216 and its new analogs
with BisPhos for more efficacious targeting of MBC BonMets, using the best Sabizabulin conjugate and paclitaxel
as the references. Conjugating Sabizabulin, SB-216, or its new analogs with a BisPhos drug with very high
affinity to bones will increase the efficacy of treating BonMets. Thus, we will optimize the linker chemistry and
evaluate a variety of BisPhos drugs for conjugation. Conjugates will first be evaluated in vitro for stability and
activation to select the two best conjugates for further in vivo efficacy studies using BonMet pre-clinical models.
Impact: The addition of a new generation of tubulin inhibitor to the existing panel of chemotherapeutic drugs
is likely to improve MBC patient PFS, OS and QOL. In addition, patients diagnosed with other types of metastatic
solid tumors in which tubulin inhibitors are currently standard of care (SOC) could also benefit from this project.

Public health relevance
Taxanes, a class of tubulin inhibitors, are a mainstay chemotherapy for patients diagnosed with stage IV breast cancer, but are limited by onset of drug resistance and dose-limiting neurological toxicities. We have discovered a new generation of tubulin inhibitors that bind to a different site of tubulin that not only bypass taxane resistance, but also are efficiently delivered to the brain. In this proposal, we will perform focused structural optimization that will be efficiently guided by X-ray crystallography and computer-aided drug design to ultimately produce a first- in-class, metabolically stable (having long duration of action in humans) tubulin inhibitor that can reverse taxane resistance and can be targeted to the brain and to bone, without inducing neurological toxicities, with the ultimate goal of eradicating established metastases to prolong survival (achieving “no evidence of disease”, NED, status).